Stabilizing the Tripartite Synaptic Complex Following TBI

Summary:
Human consciousness and cognitive function are governed by a complex brain circuitry made up of neural
connections regulated by an integrated multicellular network. Glial make up 90% of all cells in the brain and play
dynamic and active roles in neuronal signaling, where astrocytes and microglia regulate synaptic transmission
and plasticity. In the past decade, increasing evidence suggests that the principal co-agonist for N-methyl-D-
Aspartate receptors (NMDARs) is the D-amino acid, D-serine, rather than glycine; however, few studies have
examined its role in CNS pathologies. To address this gap, we have recently identified a novel mechanism of
synaptic damage, where glia within the tripartite synapse uniquely synthesize and release D-serine following the
onset of pathological events. We hypothesize that microglia are a key source of pathological D-serine that
hyperactivates extrasynaptic NMDAR subunits to initiate synaptic damage as a result of microglia targeting and
pruning of dendritic spines. Our proposed experiments will examine (1) the mechanisms of D-serine release from
microglia; (2) the mechanisms of synaptic damage and microglia targeting & pruning; (3) transcriptomic analysis
of brain injury in both murine and human models. We will achieve this by employing both genetic and
pharmacological approaches to dissect the mechanism of microglial action within the complexity of brain injury
using state-of-the-art transcriptomic, imaging, and genetic techniques. Our studies will result in a better
understanding of the mechanisms that regulate synaptic damage and dysfunction, but also will start to define
novel therapeutics for patient interventions.

Public health relevance
Narrative: Synaptic damage is associated with many neurodegenerative diseases and traumatic injuries; however, the underlying pathologies that lead to synaptic damage and losses are poorly defined. Our studies examine how prolonged release of D-serine by microglia leads to synaptic damage through hyper-activation of NMDA receptors that target dendritic spines for degradation and pruning in both murine and human tissues.